Mechanisms of Dcc Receptor Signaling in Neuronal Morphogenesis

PROJECT SUMMARY
Determining how neurons are assembled into functional circuits will provide insight into developmental
disorders of the nervous system and may suggest therapeutic approaches to promote nerve regeneration. To
navigate to their correct targets, axons must precisely modulate their responses to extracellular cues. For
example, to cross the midline commissural axons must first respond to attractive cues while preventing the
response to repulsive cues. After entering the midline, axons switch their response to allow them to be repelled
away from the midline to establish connections that are essential for coordinated sensory and motor behavior.
Netrin attracts commissural axons to the midline in both invertebrates and vertebrates through receptors of the
Deleted in Colorectal Carcinoma (DCC) family (encoded by frazzled (fra) in the fly). We have shown that Fra
(and likely DCC) signals in two ways to direct axon guidance across the midline. First, Fra responds to its
canonical Netrin ligand to promote local cytoskeletal rearrangements and second, Fra acts independently of
Netrin to directly regulate gene transcription. There are three major knowledge gaps in our understanding of
Fra and Dcc signaling mechanisms that this proposal will address: 1) the molecules that coordinate Netrin-
dependent regulation of the actin cytoskeleton during axon attraction in vivo are incompletely defined, 2) many
of the factors that control the transcriptional activity of Fra (and Dcc) are unknown, 3) the downstream target
genes that are regulated by Fra's transcription factor function and how they contribute to Fra and Dcc-
dependent processes are largely unknown. Three complementary sets of preliminary findings underpin our
proposed research. First, analysis of pathogenic variants of human DCC (hDCC) have led to the discovery of
an essential and conserved role of the Wave Regulatory Complex (WRC) in Netrin-dependent axon attraction.
Second, we have completed an in vivo proteomic screen for Fra interacting proteins and have identified and
validated several novel interacting proteins and pathways that are likely to contribute to Fra-dependent
signaling. Third, we have performed RNA sequencing in embryonic neurons isolated from Fra loss of function
and gain of function conditions and have identified a set of 15 reciprocally regulated transcriptional targets.
This preliminary data provides the foundation and rationale for the experiments that we are proposing to 1)
define how Fra/Dcc signaling recruits and regulates the WRC during axon guidance, 2) define how the
COP9 complex works with Fra to regulate transcription and 3) define the contribution of Fra's
transcriptional targets to axon and dendrite targeting. Our research will identify new molecular
components of both Netrin-dependent and Netrin-independent Fra/Dcc signaling and may inform future studies
of these signaling pathways in both neuronal and non-neuronal contexts and may offer insights into
pathological conditions in humans that are caused by aberrant DCC function.

Public health relevance
PROJECT NARRATIVE Understanding how neurons are correctly assembled into functional circuits will provide critical insight into developmental disorders of the nervous system and may inform strategies to promote neuronal repair in cases of injury or disease. Our research in this proposal will investigate the molecular mechanisms underlying the function of the conserved Dcc axon guidance receptor in promoting axon growth in the developing nervous system. Our findings will inform the study of development in many tissue types in addition to the nervous system, since axon guidance signaling molecules are known to play diverse roles during tissue morphogenesis.